Low-Dose Exposure to Ionizing Radiation in Adulthood and Subsequent Cancer

ABSTRACT
Unlike most carcinogens, which have been reduced or removed once recognized, ionizing radiation exposure
has increased in the USA over the last 3 decades. The typical American's annual radiation dose has doubled
over that period primarily due to increasing exposure to radiation from diagnostic medical procedures, such as
CT exams. The doses from such procedures are typically quite low, but may be repeated over time and
increase over adulthood.
The aim of this project is to strengthen understanding of cancer risk associated with repeated, low dose
exposure to ionizing radiation in adulthood. Among the most promising epidemiological studies of cancer risk
following low dose ionizing radiation exposures are cohort studies of people who have been individually
monitored for radiation exposure through personal radiation dosimeters. We have assembled an international
cohort of 308,000 radiation dosimeter-monitored workers from some of the world's most informative cohorts in
the United Kingdom, France, and USA. Here we propose major updates of each these cohorts and an
innovative set of analyses to directly address questions relevant to radiation protection and decision making
regarding low dose rate external ionizing radiation exposures. Specifically, we propose to assess: 1) cancer
site-specific ionizing radiation risks; 2) age-related changes in susceptibility to low dose ionizing radiation; 3)
persistence with time since exposure in excess relative rate of cancer among older adults, accounting for
competing risks; and, 4) population-level estimates of the impact of low dose ionizing radiation exposures on
cancer risk. The proposed study is likely to exert a sustained influence on the field and make a major
contribution to national and international radiation protection recommendations. The evidence from the
proposed study will help to inform cost-benefit assessments, and understanding of the role of increasing
exposures to ionizing radiation on cancer rates.

Public health relevance
PROJECT NARRATIVE This project aims to improve understanding of cancer risks from low dose radiation exposures, drawing upon recently-updated cohorts from the USA, the UK, and France. The proposed study may serve as one of the major pillars in future radiation risk assessments and will make a major contribution to our understanding of the role of low dose exposure to ionizing radiation as a cause of cancer, addressing important uncertainties in radiation protection that impact decisions regarding low dose exposures, including low dose rate effectiveness, variation with age in susceptibility to ionizing radiation, and differences by cancer site in radiation-associated cancer risks.